POTENTIAL PHARMACOKINETIC INTERACTION BETWEEN SIROLIMUS AND KETOCONAZOLE

The objective of this study is to investigate the potential pharmacokinetic interaction between sirolimus & ketoconazole. The investigator, Dr. Floren, intends to perform most of the pharmacokinetic sampling, but will utilize the GCRC staff when necessary. Also, the GCRC will be used to house our study subjects during the outpatient sampling days, to provide a core lab for sample processing, and to provide dietary support.